The Effect of Social Influence on Effort-Cost Decision-Making in Schizophrenia: From Mechanisms to Real-World Associations

PROJECT SUMMARY/ ABSTRACT
Deficits in motivated behavior and effort-cost decision-making (ECDM) are core to schizophrenia and related
disorders (SZ). ECDM paradigms show that SZ are less likely to use contextual information (e.g., reward
magnitude and probability) to drive decisions about whether to exert high effort for rewards. As such, they are
less likely to expend effort in situations when it would benefit them the most to do so. These motivational deficits
have been closely linked to functional outcomes and their treatment remains ineffective, highlighting the need to
examine factors that could enhance ECDM in SZ. Social influence (e.g., the presence of information about peer
decisions) has been shown to drive ECDM in healthy individuals (HC), particularly in conditions of low reward or
probability (when the other contextual factors may be less likely to independently do so). While there is very little
literature examining the role of social influence on effort in SZ, there is some evidence that SZ may increase
effort expenditure in response to social encouragement and that (unlike in HC) this may particularly be the case
in conditions of high reward magnitude. Thus, social factors could enhance ECDM in SZ by increasing effort in
the conditions in which it would be most beneficial to do so-- conditions in which SZ demonstrate the most
impairments. Consistent with behavioral findings that SZ are less likely to use reward-related information to
inform effortful decisions, they also may show reduced reward-related modulation in neural regions associated
with effective ECDM: ventral striatum, ventromedial prefrontal cortex, and anterior cingulate cortex. Interestingly,
these regions overlap with those involved in response to peer information and social reward, raising the
possibility that social information may modulate decisions about effort in SZ by activating neural systems that
play a role in effective ECDM. Further, to understand whether and for whom these laboratory-based neural and
behavioral markers of social influence on ECDM might lead to functional benefit in SZ, it is critical to examine
how they relate to individual differences in real-world reports of social motivation. Thus, this proposal seeks to
use a multimethod framework (e.g., behavioral task, fMRI, EMA) to examine whether social information
modulates decisions about effort expenditure in SZ as it does in HC, the neural bases of these decisions, and
real-world individual differences in social motivation that are associated with this relationship. Results from the
proposed study could elucidate the nature of social and motivational impairments in SZ and inform intervention
efforts to ameliorate these impairing deficits. The realization of this project will allow the applicant to receive
training in: 1) neuroimaging techniques and analysis, 2) the link between social processes and motivated
behavior in SZ, 3) EMA design, collection and analysis, 4) research rigor and reproducibility, and 5) professional
development. This project will help the candidate accomplish her goal of becoming an independent principal
investigator that uses multimodal approaches to investigate the mechanisms and real-world correlates of social
and motivational impairments in SZ.

Public health relevance
PROJECT NARRATIVE Effort-cost decision-making (ECDM) deficits are core to schizophrenia (SZ) and associated with poor functional outcomes. The proposed project seeks to integrate lab-based behavioral and neuroimaging paradigms with real- world measures of social motivation to investigate whether and how social influence may enhance ECDM in SZ. This project, which would provide the candidate with valuable training opportunities towards her goals as an independent researcher, could elucidate mechanisms at the intersection of social and motivational processes in SZ and pave the way for targeted interventions for these debilitating impairments.